Capacity to store critical diagnostic samples in support of Vet-LIRN activities

PROJECT SUMMARY/ABSTRACT This project involves the purchase of an IKKII Ultra Low Freezer to replace one that is aging and becoming unreliable. The new -80°C freezer will be used for microbiology sample storage related to FDA Vet-LIRN case investigations, proficiency testing, and other assigned work. Our microbiology laboratory currently serves as a Vet-LIRN network source laboratory providing veterinary isolates and metadata to the Animal Health Diagnostic Center at Cornell’s College of Veterinary Medicine in support of the Vet- LIRN Regional Whole Genome Sequencing (WGS) Project.

Public health relevance
PROJECT NARRATIVE Located 40 miles from Philadelphia and less than 150 miles from both New York City and Washington, DC, the PADLS New Bolton Center laboratory is closely located to several major metropolitan areas and provides veterinary diagnostic support to agricultural interests, animal owners, and other agencies and stakeholders in surrounding states, most notably Pennsylvania, New Jersey, Delaware, Maryland, North Carolina, and Virginia. This contact with a large portion of the Eastern United States makes the PADLS New Bolton Center Laboratory an ideal partner for enhanced regional surveillance and emergency response capabilities. Our microbiology laboratory also currently serves as a Vet-LIRN network source laboratory providing veterinary isolates and metadata to the Animal Health Diagnostic Center at Cornell’s College of Veterinary Medicine in support of the Vet-LIRN Regional Whole Genome Sequencing (WGS) Project.